Integrating machine learning to improve kidney disease risk assessment for patients on cancer therapy

ABSTRACT
As evolving therapies enable a longer lifespan for patients with cancer, risk for kidney function decline, either
pre-existing or developed as a complication of therapy, requires increasing attention. Many factors that render
serum creatinine (sCr) or cystatin-C based kidney function assessments unreliable—including sarcopenia for
the first or inflammation for the latter—are enriched in this population. Furthermore, widely used molecularly
targeted cancer medications may inhibit tubular creatinine secretion and raise serum sCr; little is known about
the long-term effects of these medications that once initiated, require long-term, daily intake. Therefore,
uncertainty about the risk for clinically significant kidney function decline among patients on molecularly
targeted cancer therapy is complicated by uncertainty about the performance of current kidney function
measures in this population. Under mentorship from experts in care of patients with cancer and kidney
disease, and in bioinformatics,
Dr. Ziolkowski will address critical data gaps in assessment of kidney function
among patients with cancer. She will take coursework in bioinformatics and apply machine learning
methodology to harness the rich health data available for a person with cancer. In a retrospective cohort of
patients treated at Stanford Health care, our team will determine the two-year incidence rate and risk factors
for progressive chronic kidney disease (CKD) for patients on cancer therapies associated with an acute rise in
sCr at drug initiation, with the hypothesis that long term exposure to these medications may contribute to
progressive CKD. We will obtain sCr, cystatin C, and kidney biomarkers of tubular injury pre- and post- drug
start to characterize the acute effects of drug initiation. We will develop a risk assessment model using
machine learning for patients on molecularly-targeted cancer therapies to predict risk of progressive CKD, with
the hypothesis that integrating multi-dimensional individual-level data in the electronic medical record will have
greater prognostic yield for progressive CKD than
estimated glomerular filtration rate cut points. We anticipate
incorporation of computed tomography (CT) measures of muscle mass and kidney size improve our risk
stratification.
We will externally validate the prediction model at Mount Sinai Health System. A risk stratification
model could identify patients at risk for progressive CKD, providing opportunities for appropriate counseling,
drug dosing, avoidance of nephrotoxins, and treatment with renal-protective medications while those at lower
risk could have expanded treatment options. Additional training in risk assessment methodologies and
machine learning will enable Dr Ziolkowski to become an independent investigator, applying the latest
bioinformatics methodologies to improve kidney function outcomes among patients with cancer. She will apply
for an investigator led (R01) grant to determine clinical utility of our risk assessment model, using simulated
and real-world prospective data, and broaden the risk assessment methodology to other cancer populations.

Public health relevance
PROJECT NARRATIVE Currently, clinicians caring for patients with cancer and other malignancies lack a framework to generate personalized risk assessments for adverse kidney outcomes and little is known about the long-term kidney effects of many first-line molecularly-targeted therapies for breast, lung, and other cancers that often cause an acute increase in serum creatinine once started. These oral medications are continued daily for months to years and the risk factors and mechanism behind the acute and progressive changes in kidney function on these medications is poorly understood. This project proposes to identify the incidence and risk factors of progressive chronic kidney disease for patients on these molecularly targeted cancer therapies associated with an acute increase in serum creatinine, determine change in kidney biomarkers of tubular injury at drug start, and develop a personalized assessment tool harnessing rich electronic health data using machine learning techniques to classify a patient on molecularly targeted cancer therapies’ risk for progressive chronic kidney disease.